Fellowship for Annabel McAtee: Elucidating the role of the dura mater in the post-stroke B cell response

After ischemic stroke, B cells play both detrimental and beneficial roles in injury and/or functional recovery
depending on responding subset and timing of activation. There is interest in developing novel immune-
modulating therapies for stroke patients, but clinical trials have had limited success, partly because key factors
that determine which subsets are helpful or harmful remain to be elucidated. Recent discoveries show that the
dura mater plays an active role in the immune environment of the brain in health and disease. Further, the dura
was recently shown to be a hub of B cell development from immature to mature antibody-secreting
populations. However, the roles of dura-localized B cells after stroke are unknown. The overall objective of this
proposal is to determine if, after stroke, B cells in the dura form antibody-secreting subsets that travel to the
brain and worsen functional recovery. This project will address a key gap in knowledge on the unique
properties of immune cells in this novel niche and may allow for the development of therapies that differentially
target these cells without affecting other populations. The central hypothesis is that, after stroke, dura-localized
B cells mature into plasma cells, travel to the brain through the arachnoid and pia mater, and release CNS
antigen-specific antibodies that impede functional recovery. To test this hypothesis, a mouse model of transient
middle cerebral artery occlusion (tMCAo) in aged male and female mice (>16 mos., n=12-18/sex), combined
with B cell depletion methods will be used. Aim 1 hypothesis is that dura B cells are exposed to more
inflammatory cytokines compared to cervical lymph node B cells, leading to a robust development of B cell
activation and maturation that is stronger than lymph node activation. This aim will achieve a full
characterization of dura B cells at 3 days, 10 days, and 7 weeks following stroke using 1) flow cytometry, 2)
histology, and 3) single cell B cell receptor sequencing. Aim 2 hypothesis is that ischemic stroke induces
maturation of dura-localized B cells that travel through the pia/arachnoid to the brain to worsen functional
outcome. This aim includes a series of selective B cell depletion assays in human (h)CD20-expressing mice
with dura versus systemic population depletion via Rituximab for 7 weeks. Motor and cognitive testing (rotarod,
Y maze) will be assessed every week and B cell depletion by niche will be confirmed. The expected outcome is
an increased understanding of the role of dura-localized B cells in post-stroke recovery, leading to eventual
development of effective immunotherapies. The trainee will gain experience with a number of experimental
techniques and statistical analyses, and will be well positioned for a career as a neurosurgeon-scientist.

Public health relevance
Recent studies show that the dura mater, a protective layer surrounding the brain, may be a location of harmful immune cell development after brain injury or disease. This project will determine if after stroke, B cells, a type of white blood cell, develop harmful features, travel to the brain directly through the meninges, and contribute to cognitive decline. These findings will allow us to better understand how dura-derived B cells differ from other cell populations after stroke, knowledge that is critical for development of immunotherapies.